BCM-Respiratory Research Training

Project Summary/Abstract
Training physicians and Ph.D. scientists can deliver impactful translational-based research in lung diseases
and bridge the knowledge gap in common respiratory ailments. This application aims to train a new generation
of scientists at Baylor College of Medicine (BCM) to increase basic and translational research in respiratory
diseases. The BCM-Respiratory Research Training (RRT) T32 program will offer scientists training
opportunities with a multidisciplinary approach using hypothesis-driven research in lung diseases. The BCM-
RRT T32 program will provide training opportunities for three candidates each year from a local and national
pool of highly qualified Ph.D., MD, and MD/Ph.D. postdoctoral trainees. A balanced alliance of MD and Ph.D.
trainees will promote the interchange of diverse ideas, broadening, and delivering new discoveries in lung
research. The BCM-RRT T32 program will emphasize the five foci of respiratory research training in
respiratory diseases that are aligned with the NHLBI priorities, and unmet clinical needs including 1)
Obstructive and Destructive Lung Diseases; 2) Fibrotic Lung Diseases; 3) Lung Infection; 4) Epidemiology of
Lung Diseases; and 5) Genomic and Bioinformatics Research. The Faculty Mentors (7 MDs, 3 MD/Ph.D., and
7 PhDs) represent a multidisciplinary group of experienced investigators from various departments at BCM,
with well-funded laboratories that broadly cover basic, and translational programs in lung diseases. Faculty
Mentors have outstanding mentoring portfolios and excellent track records of participation in training program
activities. Drs. Kheradmand and Rosas will serve as Program Co-Directors, are nationally and internationally
recognized clinician-scientists, and have been successful in training scientists to pursue federally funded
research in respiratory diseases. They are joined by a strong team of Steering Committee members (Drs.
King, Hanania, Pereira, and Rodriguez) to coordinate the recruitment and selection of candidates, oversee
the curriculum, and will be responsible for the evaluation of the mentoring team. Trainees will be guided to
assemble individual research Mentoring Committees, prepare a written research proposal, and hold Advisory
Committee reviews every six-month that include academic and career assessments. The BCM-RRT T32
program will prepare trainees for successful biomedical careers in respiratory research which will be facilitated
through the Mentoring Committee’s hands-on guidance throughout the training period. These include ensuring
that the trainees engage in impactful research and obtain local, extramural, and/or national funding, to
advance their future careers. A thorough needs assessment for incoming BCM-RRT T32 program trainees
will be conducted to clarify individual long-term plans, research agenda, needs for improving skills in writing,
oral presentation, time management, and academic goals. Securing research grants will be a priority included
in a comprehensive plan to prepare trainees as independent lung-focused research scientists.

Public health relevance
Project Narrative The education and training of the next generation of MD and Ph.D. researchers are essential to continued progress in lung health. This training application fills a critical need because it prepares scientists to work at the cutting edge of biomedical research in lung research. Therefore, this training program focuses on mentoring, career development, and advanced degrees in basic and translational research applied to lung diseases.